Use of a novel tricyclic Stk1 inhibitor to uncover molecular mechanism in clinically relevant strains of S. aureus

Project Summary/Abstract – Dr. Heather Miller, PI
The kinase Stk1 controls genes involved in antibiotic resistance, biofilm formation, and
toxin expression in virulent strains of Staphylococcus aureus. There is a critical need to determine
its mechanism of action. Without this information, there are key details missing about an important
tool in minimizing antibiotic resistance. Inhibition of Stk1 in vitro potentiates methicillin-resistant
S. aureus (MRSA) to b-lactam antibiotics, making it an attractive target for the development of
novel antibiotic adjuvants. However, studies of stk1 deletion mutants have produced contradictory
results about this protein’s role in virulence. Considered a master regulator, it is difficult to predict
the full consequences of Stk1 inhibition. Additionally, the strain-specific differences in downstream
gene expression affected by Stk1 phosphorylation have prevented comprehensive understanding
in a medically relevant context. It is not clear yet how Stk1 inhibitors elicit these antibiotic adjuvant
effects. The long-term goal of this research is to develop novel anti-virulence treatments to combat
persistent and antibiotic resistant bacterial infections. Our overall objectives are to confirm the
molecular target of the lead compound in S. aureus, investigate this Stk1 inhibition in clinically
relevant strains of MRSA, and develop genetic tools to decode mechanistic details of Stk-1
mediated b-lactam resistance. Our central hypothesis is that our lead compound represents a
promising antibiotic adjuvant scaffold that targets the master regulator Stk1. To test this
hypothesis, adjuvants will be used as chemical probes to interrogate the Stk1 domain(s)
necessary for binding. Comparative transcriptomics will be used to investigate Stk1-mediated
gene expression across several strains of MRSA to elucidate differences that could affect
development of broadly active inhibitors. Finally, genetic tools will be developed that will
systematically mutate phosphorylated substrates to trace Stk1-mediated b-lactam resistance
pathways in these clinically relevant MRSA strains. Upon completion of the proposed work, we
expect to contribute to the existing knowledge of virulence pathways and their regulatory
mechanisms in S. aureus. This work is innovative because the experimental design does not
adhere to the status quo. We will not only investigate transcriptome-wide changes across clinically
relevant strains, but also with adjuvant molecules alone and in combination with antibiotics to
provide a more medically relevant context. These results will have a significant impact as they will
afford necessary information for evaluation of Stk1 as a therapeutic target, thereby providing
crucial new information for the development of novel antibacterial therapies.

Public health relevance
Project Narrative – Dr. Heather Miller, PI The proposed research is relevant to public health because it will utilize a comprehensive chemical biology approach to expand our understanding of Stk1, the kinase that regulates antibiotic resistance, virulence, biofilm formation, and toxin expression in Staphylococcus aureus. Elucidation of Stk1 domains required for inhibition of activity and pathways under its control will provide critical insight that can be leveraged into novel therapies to treat S. aureus infections in a variety of strains. Thus, the proposed research is relevant to the part of the NIH and NIGMS mission that pertains to pursuing basic research to increase understanding of biological processes that will advance disease treatment and prevention.